Immunologic Basis of Resistance and Hypersensitivity

Project Summary
This continuation of an established training program seeks to prepare qualified M.D., Ph.D., and M.D./Ph.D.
candidates for academic careers in the field of allergy and immunology. Support is requested for eight
postdoctoral trainees having either a M.D. or Ph.D. degree or both. The training program emphasizes three
major areas: basic science, translational science, and clinical science. The trainees focused in basic science
learn techniques and concepts of immunopharmacology, immunochemistry, and cellular and molecular
immunology. Areas of emphasis include the basic biology of mast cells, lipid mediators, dendritic cells, innate
lymphoid cells, and animal models of allergic disease. Trainees in translational science paths incorporate
informatic approaches to analyze genetic, genomic, and unbiased sequencing or metabolomic data to
understand the mechanistic basis of human allergic diseases. Such trainees may also employ bench side
approaches to studies using human cells and tissues. Trainees in clinical sciences may focus on epidemiology
or clinical trials. The faculty are highly accomplished investigators with extensive mentoring track records and
substantial extramural grant support. The three-year research training period is designed so that each trainee
learns a range of techniques and approaches, gains a broad understanding of the innate and adaptive immune
host responses, and establishes a template for an early career research focus. This time frame also permits
the trainee, along with his or her mentor and Scholarship Oversight Committee, to plan for post-fellowship
career development, with the goal of defining a path in academia that is commensurate with the trainee’s
developing skills and interests. The research experience is enhanced by didactic course work, as well as
workshops in grant writing, manuscript composition, and lab management. The program continues to be highly
successful, with over 75% of the graduates in the past decade having full-time academic appointments, many
of whom are primarily research based with independent NIH support.

Public health relevance
Project Narrative Allergic diseases such as asthma, hayfever, and food allergy are a growing public health problem. This grant supports the training of academic scientists and physician-scientists, preparing them for careers as investigators into the causes and treatments of these diseases, with the goal of improving diagnosis, prevention, and therapy of allergic diseases.